Specificity Screening Drug Development Tool for Biotherapeutic Safety

ABSTRACT
Off-target safety problems are the single leading cause of preclinical drug failures. As a result, specificity
profiling has become an FDA requirement for monoclonal antibodies (MAbs) as well as other emerging
biotherapeutic categories such as CAR-T cell therapy. Current methods for profiling the specificity of
biotherapeutics, primarily tissue cross-reactivity studies (TCR) and spotted protein arrays, are poorly predictive
of cross-reactivity against the native human proteome, have low sensitivity, and are difficult to interpret. A
novel approach for specificity profiling is needed to better predict off-target binding of MAbs and de-risk
biotherapeutic discovery programs. Integral Molecular is the industry leader in membrane protein antibody
discovery and characterization. As a result of previous SBIR funding, we developed a new technology for
specificity profiling and deorphaning, the Membrane Proteome Array (MPA). The MPA represents 93% of the
human extracellular proteome expressed in their native conformation in live cells. Recently, the MPA was the
first technology accepted into the FDA’s ISTAND pilot program for drug development tools (DDT).
Development of the MPA would have a large impact on the clinical pipelines of nearly every biopharmaceutical
company and has significant commercial potential.

Public health relevance
PROJECT NARRATIVE This proposal will contribute to public health and the cure of human disease by resulting in an FDA compliant tool for testing biotherapeutic cross-reactivity, enabling the development of therapeutic candidates with markedly improved likelihoods of succeeding in preclinical and clinical trials. The MPA will significantly decrease the number of unsafe therapeutics that enter preclinical and clinical trials and ultimately fail due to safety risks.